PROTECTIVE MECHANISMS WITH ATTENUATED LENTIVIRAL VACCINES

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. HIV is a sexually transmitted disease and a vaccine capable of preventing sexual transmission of HIV should elicit mucosal immune responses in the genital tract. The objectives of this study were to determine which immune responses confer protection from intravaginal challenge with SIVmac 239.